Modulating Human Microbiome Function to Enhance Immune Responses Against Cancer

PROJECT SUMMARY
Cancer immunotherapy has been one of the great recent breakthroughs in cancer treatment options.
Antibodies that antagonize immune-inhibitory receptors, a therapy type known as immune checkpoint blockade
(ICB), show great promise and further improvements in response rates and durability are likely with additional
research. The potency of this cancer therapy demonstrates its incredible potential, and yet for most cancer
patients these amazing benefits are currently unattainable. One current challenge in checkpoint blockade
therapies is understanding the highly variable responses across patient cohorts. The gut microbiome, a major
source of interindividual biological variability, is known to impact systemic immune status and specific features
of microbiome composition have been linked to ICB in multiple human studies. Tests of causality in animal
models of ICB have confirmed that addition of certain bacterial species to the gut microbiome induces
improved tumor control. However, inconsistencies of implicated microbial species between studies and the lack
of insight into molecular mechanisms that underlie the microbiome’s impact on response leave a large gap in
understanding. The central hypothesis of this proposal is that discrepancies in findings between studies that
focus on compositional associations are explained by a shared functional basis within phylogenetically distinct
taxa. Since functions encoded by the gut microbiome are the mediators of interactions with the host, and are
often shared between unrelated bacteria, a function-focused approach to study the microbiome’s effect on ICB
is needed. This proposal addresses field-wide challenges in pursuing microbiome function by leveraging a
broad array of tools that have been developed for the purposes of investigating microbiome functions and
understanding mechanistically how they impact host biology. The goal is to identify bacterially encoded
functions that enhance response to ICB. Aim 1.1 proposes metagenomic data aggregation and analysis across
immunotherapy studies to identify genes associated with ICB response; the cutting-edge data analysis pipeline
applied to all available data addresses previous limitations like study specific analysis choices and small cohort
sizes. In Aim 1.2, isogenic pairs of bacteria that do or do not express the genes of interest will be genetically
engineered; function and phenotypic differences will be characterized in culture. Aim 2 will test the impact of
candidate genes/functions by colonizing a mouse model of cancer with one of each pair of isogenic bacteria
and comparing ICB-mediated tumor control. In cases where microbial genes/functions enhance ICB mediated
tumor control, microbiome focused metabolomics and immunological characterization of gut, tumor, and other
immune compartments will provide insight into immune mediators of the effect. Definitive identification of
microbiome encoded functions and mechanistic connections that determine gut microbial impact on ICB will
inform individualized therapeutic suitability and enable the development of therapies that augment ICB.

Public health relevance
PROJECT NARRATIVE A complex community of microbes, known as the microbiota or microbiome, lives within our distal digestive tract and is intimately connected to the human immune system. Immune checkpoint blockade is a promising immunotherapy for the treatment of cancer but success is highly variable across individuals and response to the therapy is likely impacted by the individuality of the gut microbiome. This project will identify genes within the gut microbiome that enhance responsiveness to cancer immunotherapy and test these candidates as potential new therapeutic approaches to improve cancer treatment.